Mechanisms of microbiome-driven cardiac allograft outcomes

PROJECT SUMMARY
Though the one-year survival rate in cardiac transplantation has reached 90-95%, the mortality rate beyond the
first year has not changed in the last two decades. Immune-mediated damage remains the primary cause of
long-term graft failure. Findings from our and other studies provide the rationale for investigating the gut
microbiome as a determinant of post-transplantation outcomes and as a potential tool to induce immune
modulation to improve long-term graft outcomes. The goal of this study is to determine the mechanisms by
which the gut microbiome impacts allograft outcome. We postulate that the disrupted metabolic activities of the
gut microbiome lead to inflammatory responses and intestinal injury via cell-type specific responses in the
intestinal cells network, which subsequently modulate alloimmunity and ultimately chronic cardiac graft
outcomes. We will take advantage of our clinically-relevant cardiac transplant murine model of chronic rejection
with well-characterized alloresponses, induced by pro- or anti-inflammatory bacteria, to determine the
alterations in the microbial metabolic activities in Aim 1, then to identify local intestinal barrier changes and the
underlying intestinal cell-type specific responses in Aim 2, and finally to characterize systemic alloresponses
and graft survival in Aim 3, in order to obtain a holistic understanding of the precise mechanisms of
microbiome-driven chronic graft outcomes. The proposed work will identify novel and critical microbiome-based
targets for diagnostic application and therapeutic intervention, and discern the complex and bidirectional
dialogue between the microbiome and alloimmunity to promote transplant immunologic quiescence and long-
term cardiac graft survival.

Public health relevance
PROJECT NARRATIVE The long-term survival rate in cardiac transplantation is poor, and immune-mediated damage remains as the primary cause of chronic graft failure. This study addresses major knowledge gaps in the mechanisms by which the gut microbiome induces immune modulation that could prolong immunologic quiescence to improve graft survival. This is a fundamental step towards novel advances in diagnosis and preventive therapeutics against graft rejection to improve health and quality of life, all of which are within the mission of NIAID.